Motivational interviewing and air cleaners for smokers with COPD (MOVE COPD)

COPD is characterized by lung injury and inflammation caused by noxious particles and gases, including those
emanating from cigarette smoke and air pollution. Unfortunately, current active smokers represent the largest
subset of COPD in the US and most individuals with COPD are not successful at quitting even though smoking
cessation is the best option. A potential harm reduction strategy for those who will not or have not yet
successfully quit, that has not been tested and has no health risk, is improvement of air quality. The indoor
environment is of particular concern as patients with moderate to severe COPD spend the majority of their time
in their homes. People with COPD who have higher exposure to indoor pollutants, including particulate matter
(PM), second hand smoke (SHS), and nitrogen dioxide (NO2) have worse respiratory morbidity including a
higher risk of exacerbations. These effects are not obscured by their smoking habit. Unfortunately, despite the
clear detrimental impact of poor air quality on respiratory outcomes, regardless of smoking status, to our
knowledge, there are no studied environmental interventions targeting indoor air quality to improve respiratory
health of smokers, thus ignoring a potential target for harm reduction. Our group has substantial expertise in
conducting trials successful at reducing harmful indoor exposures including 1) home interventions utilizing
portable air cleaners with high efficiency particular air and carbon filters that significantly reduce indoor PM and
NO2 concentrations, and 2) behavioral interventions including Motivational Interviewing (MI) to promote health
behavior change and reduce home air nicotine levels and indoor SHS. We propose a randomized controlled
intervention trial to test whether targeted reductions of multiple indoor pollutants (PM, SHS and NO2) in homes
of smokers with COPD will improve respiratory outcomes. We have chosen a potent, multimodal intervention in
order to maximize the opportunity to prove that there is a health benefit to active smokers with COPD from
indoor air pollution reduction. After a one-month run in period in which all participants will receive smoking
cessation strategies including MI and nicotine replacement therapy, participants unable to quit smoking
(n=120) will have 1:1 randomization to receive either 1) multi-component environmental intervention (active air
cleaners + MI intervention for SHS reduction) or 2) sham air cleaners. All participants will continue to receive
smoking cessation counseling throughout the study period, including those that quit smoking during the run in
period. We aim to determine whether a multi-component environmental intervention (targeting PM, SHS and
NO2 reduction) will improve respiratory morbidity (i.e., symptoms, quality of life, lung function and exacerbation
risk) (Specific Aim #1) and intermediate outcome measures (i.e., markers of airway and systemic inflammation
and oxidative stress) (Specific Aim #2) in smokers with COPD. We anticipate that results from this study will
inform clinical practice guidelines and health care policies aimed at reducing COPD morbidity and may have
broader implications for indoor environmental recommendations for smokers with chronic disease.
1

Public health relevance
Project Narrative Chronic obstructive pulmonary disease (COPD) is a progressive disease characterized by lung injury and inflammation, and is the third leading cause of death in the United States with substantial economic costs. Active smokers represent the largest subset of COPD in the United States and unfortunately indoor air quality intervention studies to date have generally excluded assessing health impacts in smokers; therefore we propose a multi-component environmental intervention to improve home air quality to test whether reductions of indoor pollutants will provide a health benefit for smokers with COPD. We anticipate that results from this study will inform clinical practice guidelines and health care policies aimed at reducing COPD morbidity and believe that our study results may have broader implications for indoor environmental recommendations for smokers with chronic disease.